Impact of Lifestyle Disruptions on Problem Drinking in Young Adulthood

PROJECT SUMMARY
Problem drinking, defined as recurrent moderate-to-heavy drinking (3-14 drinks/week for men, 2-7 drinks/week
for women)31, is a common behavior in young adulthood. Despite risks, interventions aimed at reducing
problematic alcohol use among young adults yield only modest effects. One potential reason is that, among
many contributing factors, drinking can be a habit37. Habits are behaviors that occur in stable contexts (same
people, places, times), and that are independent of intentions. Instead, habits rely on internal and external
contextual cues that have been consistently associated with the activity39. When cues are disrupted, habits are
also flexible to change. To the extent that non-pathological, yet problematic alcohol use can be habitual,
periods characterized by changes could open opportunities for shifts in problem drinking behavior. Young
adulthood is one such period of multiple life disruptions and is often characterized by changes to habit-
sustaining cues, including environments, social networks, and activities. Young adulthood may thus be a
unique “window of opportunity” for translating intentions into change39. This project aims to 1) identify whether
problem drinking can function as a habit; 2) identify whether habitual problem drinking can be disrupted during
transitions; and to 3) determine whether effortful processes (e.g., intentions, self-regulation) supersede habits
when cues are disrupted. The proposed project will involve participant recruitment, data collection, and
analysis for two studies. Studies will leverage a participant population enrolled in a large project maintained by
the Sponsor’s NIDA-funded Center, as well as previously collected data and resources from the Center. The
applicant’s long-term career goal is to approach the study of substance use from multidisciplinary perspectives
and to capably communicate with translational research scholars to inform prevention and intervention efforts,
ultimately reducing the impact of alcohol use on individuals and society. The applicant’s specific training goals
involve complementing current training in social sciences, research design, and statistics by: 1) gaining
knowledge of the neurobiology of alcohol use and its effect on the developing brain; 2) application of intensive
longitudinal methods and data analysis for the study of alcohol use in daily life; 3) gaining foundational
knowledge of prevention science and translational research as it relates to alcohol use; 4) enhancing skills in
publication, dissemination, and networking; and 5) gaining further training in grant writing. The proposed
training plan was strategically developed to accelerate the applicant’s development as an independent social
sciences researcher with a multidisciplinary approach and knowledge of alcohol use, as well as skills to test
complex models using diverse designs and analytical strategies.

Public health relevance
PROJECT NARRATIVE The proposed research will examine whether problematic drinking operates like other habitual behaviors: reliant on contextual stability, free of intentions, and reduced upon disruption of contexts that sustain it. By leveraging typically-occurring transitions in young adulthood as instances of disruption, this work will help identify a window of opportunity for translating intentions into changes and enhancing the effectiveness of alcohol use prevention and intervention efforts.